ROLE OF CYTOKINES IN THE PATHOGENESIS AND TREATMENT OF AUTOIMMUNE DISEASE

We have focused our studies on an analysis of the pathogenesis of Experimental Allergic Encephalomyelitis (EAE), an animal model for the human demyelinating disease, multiple sclerosis. The cytokine, IL-12, which is produced by monocytes and dendritic cells, has been shown to play a critical role in the generation of the subpopulation of T lymphocytes (T helper 1[Th1] cells) which mediate EAE. Our studies have demonstrated that the successful differentiation and/or function of autoimmune effector cells is dependent on their ability to respond to quantities of IL-12 that are available in the microenvironment during critical time points. The interleukin (IL)-12 receptor beta2 subunit is the key molecule involved in maintaining IL-12 responsiveness and controlling Th1 lineage commitment. Both IL-12 and interferon-gamma were shown to play separate as well as complementary roles in regulating IL-12 receptor beta2 expression on antigen-specific CD4+ T cells. The B10.S strain of mice is resistant to the development of EAE and was shown to have an antigen-specific defect in the expression of the IL-12 receptor beta2 subunit. Defective expression was secondary to a failure of the MBP-specific Th1 cells to express the membrane antigen, CD40 ligand, which is required for the T cell mediated induction of IL-12 production by macrophages/dendritic cells. IL-12 receptor expression as well as the capacity of Th1 cells from B10.S mice to induce EAE could be restored by the addition of IL-12. As these studies suggest that the development of immunotherapies that target the IL-12 receptor may be useful in the treatment of autoimmune diseases, we have initiated an extensive analysis of the regulation of IL-12 receptor expression by soluble factors and cell associated molecules. IL-18 was originally described as a cytokine which induced interferon- gamma production by established Th1 cells in an IL-12 independent manner. However, subsequent studies demonstrated that exogenous IL-18 in the absence of IL-12 failed to drive Th1 differentiation of naïve T cells and induced interferon-gamma from established Th1 cells only in combination with IL-12. We have demonstrated that the primary effect of IL-18 on Th1 differentiation is mediated by its capacity to directly upregulate IL-12 receptor expression which thereby enhances IL-12 mediated signaling. The enhancement of IL-12 receptor expression by IL- 18 may be particularly important for the differentiation of foreign antigen- or autoantigen-specific Th1 cells when the stimulatory concentration of IL-12 in the microenvironment is just below the threshold required for Th1 development. The other major factors which we have identified as important in regulation of IL-12 receptor expression are costimulatory signals delivered to the antigen-specific T cells by interactions of the CD80/CD86 molecules on antigen presenting cells with CD28 on the T cell. We have demonstrated that costimulation is required for production of both IL-2 and IL-12 and that both of these cytokines are critical for the ability of T cells to express IL-12 receptors and to differentiate into pathogenic autoreactive T cells. - Autoimmune disease, multiple sclerosis, central nervous system, experimental allergic encephalomyelitis, T helper 1 lymphocytes